ZDV VS. DDI VS. ZDV PLUS DDI IN SYMPTOMATIC HIV-INFECTED CHILDREN

This study is aimed at comparing the safety and efficacy of therapy with Zidovudine versus 2',3'-dideoxyinosine (ddI) versus a combination of ZDV and ddI.